17th and 18th International Symposium on Cells of the Hepatic Sinusoid

DESCRIPTION (provided by applicant): This R13 application requests support for the 17th and 18th International Symposium on Cells of the Hepatic Sinusoid (ISCHS) to be held in Osaka Japan in Sept 2013 and Cleveland OH in Sept 2015. The application requests support for the participation of invited expert speakers, as well as for young clinical and basic investigators. Th goal of the ISCHS is to bring together an international group of multidisciplinary scientists, including established and new investigators, as well as pre- and post-doctoral trainees, who are interested in the common questions: How does the cross-talk between different liver cell types in the hepatic sinusoid facilitate liver development and growth, homeostasis and pathological outcomes in disease? Participants at the meeting will present cutting edge, high quality research which begins to identify novel molecular and cellular interactions within the liver sinusoid. There are surprising gaps in our understanding of this basic unit of functional activity n the liver; advances in hepatic sinusoidal cell biology are critical to understanding the cellular basis of alcoholic liver disease (ALD). The ISCHS represents the only international organization which gathers leading investigators in liver biology and hepatocellular cross talk from around the world. This meeting will facilitate and promote: 1) international collaborations between different countries with populations differing in their genetics and social backgrounds who suffer from ALD, 2) resource sharing between international investigators, generating synergy and unique ideas and 3) interaction of trainees at the international level. Taken together, the unique environment of the ISCHS is an ideal format for cutting-edge interactions on the potential implications of their research into the pathogenesis of ALD, helping to synergize research that will fill these gaps and advance the frontier of research in ALD and development of preventative and therapeutic treatments.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application seeks support for organizing the 17th and 18th International Symposium for Cells of the Hepatic Sinusoid, to bring together scientists interested in the function of the cells of the hepatic sinusoid in health and disease. Advances in hepatic sinusoidal cell biology are critical to understanding the cellular basis of alcoholic liver disease. By providing a forum for experts from many disciplines to discuss the problems related to alcoholic liver disease and share their latest data, new scientific questions and new directions in the field are likely to emerge. Ultimately, these will lead to scientific breakthroughs that wil define new treatments for liver injury caused by alcohol. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Alcoholic liver disease (ALD) develops in approximately 20% of all alcoholics, in a complex process involving both parenchymal and non-parenchymal cells resident in the liver, as well as recruitment of other cell types to the liver in response to damage and inflammation. The fundamental functional unit of the liver is the hepatic sinusoid. Within the sinusoid, there is critical crosstalk between hepatocytes with non- parenchymal liver cells (hepatic macrophages, sinusoidal endothelial cells, hepatic stellate cells, NK cells, NKT cells) during development, as well as in health and disease. Interactions between the cells of the hepatic sinusoid are finely regulated; disruption in either the initiation and/or termination of signaling and responses can contribute to the progression of ALD. Given the critical nature of these cell-cell interactions within the hepatic sinusoid, there are surprising gaps in our understanding of this basic unit of functional activity in the liver. Advances in hepatic sinusoidal cell biology are critical to understanding the cellular basis of ALD. The 17th and 18th International Symposium on Cells of Hepatic Sinusoid (ISCHS) to be held in Osaka, Japan and Cleveland, Ohio, respectively are a continuation of historical biannual symposia which began in 1977. These meetings epitomize cutting-edge science of hepatic sinusoidal cell biology essential for better understanding of the pathophysiology of ALD. ISCHS assembles internationally recognized scientists from around the world who are primarily interested in the interactions among the liver cell types as critical events for the pathogenesis of steatohepatitis, liver fibrosis, liver cancer, ischemia-reperfusion injury associated with liver transplantation, the pathologic entities intimately associated with ALD. The specific objectives of the meeting are to: 1) Provide a forum for scientists from various countries and disciplines to exchange advances in their own research in relation to the roles of liver sinusoidal cells in ALD, and introduce emerging areas of innovative cell-type specific research to the alcohol research community. 2) Allow researchers from various countries to form multi-center and multi-national collaborations on basic and clinical research related to alcohol or ALD. 3) Facilitate interactions between basic and physician researchers in promoting innovative translational research which may lead to the development of new diagnostic and therapeutic modalities toward liver disease such as ALD. 4) Increase the involvement of young investigators in the study of sinusoidal cell biology and ALD through travel awards and interactions during the meeting. Each meeting hosts state-of-the-art lectures by distinguished scientists and tutorial lectures on methodological issues by leading investigators in respective thematic areas. It also provides a platform for 24 short oral presentations, to be filled with a combination of invited speakers and original research presentations selected from the submitted abstracts. The meeting can accommodate 100 poster presentations to stimulate interactions and discussions among participants in several thematic sessions. Participation by women, racial/ethnic minorities, persons with disabilities, and other individuals traditionally underrepresented in science will be encouraged during selection of speakers and poster submissions. One important unique feature of the ISCHS is that it is historically attended by scientists from multidisciplinary fields such as anatomy, physiology, cell biology, developmental biology, hepatology, surgery, and oncology, as well as clinical and translational investigators. This provides rare but ideal opportunities for invaluable interactions by multidisciplinary participants which will lead to the emergence of new concepts, ideas, and collaborations in the field of ALD.